DOUBLE BLIND,PLACEBO CONTROLLED,DOSE RANGING STUDY OF DOPAMINE RECEPTOR AGONIST

The purpose of this study is to 1) investigate the safety, tolerability, and pharmocokinetics of an intravenous formulation of the dopamine D1 receptor agonist, ABT-431, in cocaine abusers and 2) determine whether ABT-431 is effective in reducing the behavioral responses to intravenous cocaine in cocaine abusers.